Carbamylation, smoking, and asthma

Second hand tobacco smoke exposure is the single largest risk factor for asthma-related morbidity and mortality. Remarkably, the mechanisms contributing to asthma exacerbations and progression of disease following either acute or chronic environmental tobacco smoke exposure (ETS) are not fully understood. We discovered a novel mechanism linking smoking exposure, Inflammafion and cardiovascular disease risk that nvolves post-translafional modificafion of proteins via carbamylafion, a chemical process facilitated by the leukocyte peroxidase myeloperoxidase (MPO) In the presence of thiocyanate (SCN"), an anion normally found in plasma whose levels are substanfially elevated by smoking (>5 fold) and second hand tobacco smoke exposure (>2-fold). Strikingly greater increase In protein carbamylation occurs within asthmatic ainways of humans, and in animal (mouse) models of asthma following allergen challenge. In unpublished studies we show that eosinophil peroxidase, a related member of the heme peroxidase superfamily known to be enriched and active witiiin human asthmatic ainways, is much more efficient than MPO at promoting protein carbamylation at normal plasma levels of SCN". EPO-catalyzed protein carbamylation induces mulfiple asthma-associated phenotypes including induction of ainway epithelial cell apoptosis, MUC5AC expression and mucin accumulafion. Protein carbamylafion co-localizes with EPO In lung biopsies from asthmatic subjects. Our overall hypothesis is that protein carbamylation Is a fundamental process intrinsic to eosinophilic Inflammatory disorders and serves as a mechanism linking smoking and asthma pathogenesis in humans. To test this, we will examine levels of carbamylated protein in the ainways, plasma and urine of asthmatics and relate this to disease severity and exposure to ETS. Using mouse models of allergeninduced asthma we will determine if EPO is the major heme peroxidase responsible for generating carbamylated protein In the asthmatic lung and examine if ETS alters this. Finally, we will examine if carbamylated protein alone can elicit many of the pathopysiological asthma phenotypes, such as mucus plugging and ainway epithelial cell apoptosis in primary human and mouse cells in vitro and in wildtype and SR-AI KO animals in vivo. The information obtained will be used to define novel targets for treatment of asthma (e.g. SR-AI decoy receptors), and identify molecular (diagnostic) biomarkers for monitoring inflammatory in asthma that may help guide tailored therapeutic regimens. Project 1 works closely with the three other projects and cores towards mechanistic understanding of asthma that Is directed towards design of innovafive approaches to Improve asthma care.